The PILI 'Āina Project

SUMMARY
Native Hawaiians have the highest prevalence of cardiometabolic diseases of any population in Hawai‘i. Diet is
strongly implicated as a cause of these disparities. Native Hawaiians historically consumed a diet rich in fish,
fresh fruits, and vegetables, but Westernization led to profound shifts in food systems. The Hawaiian Homes
Commission Act established a land base for Native Hawaiians to engage in subsistence living and practice their
culture. However, today only 20% of Native Hawaiian homesteaders consume at least 1 serving of vegetables
per day compared with 73% of other Native Hawaiians. Homesteaders also have twice the prevalence of diet-
related diseases (obesity, diabetes, hypertension, dyslipidemia) than other Native Hawaiians. We have
developed a multilevel intervention to promote healthy eating, weight loss, and cardiovascular health for
overweight/obese Native Hawaiian adults entitled “PILI ‘Āina.” At the individual-level PILI ‘Āina provides 3 months
of culturally tailored education based on the Diabetes Prevention Program’s Lifestyle Intervention. The education
aims to improve self-management of prevalent cardiometabolic disease (type 2 diabetes, hypertension, and
dyslipidemia) and to reduce risk factors for developing new diet-related illness. PILI ‘Āina also includes a 6-
month household-level component that provides home garden materials and training as a means of connecting
with traditional NH culture, values, and lifestyle in the home environment. A pilot study of PILI ‘Āina was well-
received by participants, with 100% retention over 9 months and promising results for cardiometabolic outcomes.
We will now conduct a group-randomized controlled trial of PILI ‘Āina on 7 O‘ahu homesteads. First, we will
interview the past PILI ‘Āina pilot participants to refine the intervention to better support year-round home
gardening and a traditional Native Hawaiian diet. Second, we will conduct a group-randomized controlled trial
to test the efficacy of PILI ‘Āina compared to a control group among 180 adult homesteaders with
overweight/obesity who have at least 1 other cardiometabolic disease. Data collection will occur at baseline and
3, 9, and 12 months. Primary outcomes are diet quality, adiposity, hemoglobin A1c, blood pressure, and lipids.
Secondary outcomes are behavioral and psychosocial factors (e.g., physical activity, self-efficacy) that might
mediate effects on primary outcomes. Third, a community-level program will feature traditional cooking and
tasting events on all 7 homesteads. Our Specific Aims are to 1) Refine the PILI ‘Āina intervention to optimize
its effectiveness for improving diet and managing diet-related cardiometabolic diseases on Native Hawaiian
homesteads; 2) Test the efficacy of PILI ‘Āina compared to a control group for improving diet, biomarkers, and
behavioral and psychosocial risk factors among homesteaders with diet-related cardiometabolic diseases; and
3) Evaluate the ability of community-wide food demonstrations to promote traditional diets and improve social
cohesion on Native Hawaiian homesteads. Results will address the American Heart Association’s call for
evidence-based programs to improve diet at the household level for preventing cardiovascular disease.

Public health relevance
PROJECT NARRATIVE Native Hawaiians’ traditional lifestyles and diets that ensured mutual health and wellbeing of the land and its inhabitants stand in stark contrast to the disproportionately high prevalence of diet-related, cardiometabolic diseases they experience today. In this project, we will adapt and test an evidence-based multilevel intervention entitled PILI ‘Āina to improve the self-management of prevalent cardiometabolic diseases and reduce risk factors for developing new diet-related illness and implement and evaluate the impact and sustainability of community- wide cooking demonstrations. The objectives of this project are to optimize the effectiveness and sustainability of PILI ‘Āina, improve diet quality and cardiometabolic markers and promote traditional Native Hawaiian diets and improve social cohesion.